ICEMR Data Management Core

Project Summary – Burkina Faso ICEMR Data Management Core The Data Management Core (DMC) of the Burkina Faso ICEMR will provide infrastructure and oversight for the coordination of data collection and analysis occurring across ICEMR institutions in Burkina Faso (IRSS and INSTech) and in the U.S. (Yale and CSU). The DMC will be based at Yale, using the experience and standard procedures developed in the Yale Data Coordinating Center (YDCC), and their faculty and staff expertise in informatics, biostatistics, epidemiology, clinical trials, and health services research, along with a highly trained technical staff skilled in systems programming, data management, data analysis, and statistical programming. The DMC will be composed of a Core Leader/Biostatistician (Yale; Dzuira), a Senior Data Manager (Yale; Simone), a Clinical Data Manager (Yale; Parikh), a Spatial Epidemiology Lead (CSU; Hemming-Schroeder), Field-based Data Core Leader/Biostatistician (IRSS; Somda), and an IT/Data Management co-lead (INSTech; Gnoumou). The DMC will design, develop, test, and maintain the study database, which will be a REDCap data management system; develop and implement uniform procedures for secure collection of high quality data; prepare and disseminate data sets to sites for analysis; submit data to a data sharing repository (ClinEpiDB); and provide biostatistical support for protocol design as well as development of analytic plans and oversight of analyses.